Understanding glaucoma risk and assessment of precision therapies: A study of mitochondria and oxidative stress in human trabecular meshwork

Project Abstract:
Understanding the pathogenesis of glaucoma, a leading cause of blindness worldwide, is an important goal
of vision research. As indicated in numerous population-based studies, individuals of African descent
develop glaucoma at an earlier age with increased severity and risk of blindness. Many studies have
identified oxidative damage to the trabecular meshwork (TM) cells, leading to decreased outflow facility and
increased intraocular pressure. Although the evidence linking oxidative damage to glaucoma is strong, the
causes of oxidative damage in glaucoma are not known. In the proposed studies, we will test the hypothesis
that oxidative damage to the TM is associated with basic genetic and physiologic differences in oxygen
metabolism leading to disparities in glaucoma based on racial background. Our hypothesis is based on
intraocular measurements of oxygen partial pressure (pO2) made in the human eye during surgery. We
identified strong correlations between pO2 and important risk factors for glaucoma, including central corneal
thickness and African-American/Black (B) heritage. In addition, measurements of a cell marker for DNA
oxidative damage were elevated in the aqueous humor of B patients with severe glaucoma compared to W
patients. Cultured TM cells from B healthy donors compared to W cells had altered energy (ATP) and
reactive oxygen species production, implicating the energy processing organelles, the mitochondria. Our
specific aims will test these hypotheses: (Aim 1) will evaluate differences in TM gene expression between B
and W donor controls and in patients at various glaucoma stages in order to identify the genetic basis of
disparities in tissue function (controlling eye pressure) and susceptibility to damage. Genes of interest will
be further studied (RT-qPCR, in situ hybridization) and delineate protein expression (Western blot) in the
tissue and potential biological pathways involved, focusing on mitochondrial function, oxidative stress and
antioxidant protection. (Aim 2A) will study mitochondrial functions in primary human TM cell cultures from
specimens of B and W healthy donor controls and glaucoma patients at various severity stages. We will
determine the effects of racial differences and exposure to varying levels of pO2 on detailed analyses of
mitochondrial quantities and function, reactive oxygen species levels and antioxidant protection. (Aim 2B)
will also assess the cellular effects of potential antioxidative therapies. The proposed research is innovative
because understanding these physiological mechanisms potentially contributing to disease disparity based
on racial ancestry, confirmed by blood and tissue ancestral genotyping and mitochondrial DNA haplogroup
stratification, will provide important information about the pathophysiology of open angle glaucoma by
identifying factors responsible for the TM dysfunction and loss of aqueous outflow facility. The knowledge
gained in these studies may lead to new therapies and strategies to prevent this blinding disease.

Public health relevance
Modified Public Health Relevance Section Glaucoma, a leading cause of blindness worldwide and frequent cause of visual impairment in the US, is an important public health issue, affecting particular individuals at an earlier age and more commonly resulting in blindness. By exploring the tissue-specific genetic and physiologic basis of these differences, our research will provide support for our hypothesis proposing differences in oxygen/mitochondrial metabolism and oxidative stress (from “toxic” free radicals) within the tissues (trabecular meshwork) of the drain of the eye that controls eye pressure, the most significant modifiable risk factor for glaucoma. Improving our understanding of how certain individuals are more susceptible to damage will also expand potential novel pathways of therapy and prevention for all individuals afflicted by or at risk for this blinding disease.